Elucidating the mechanisms underlying DNA double-strand break repair

PROJECT SUMMARY
Our genomes are under constant threat due to the accumulation of DNA damage that arises from normal cellular
metabolism and environmental hazards. DNA damage is a key driver of several human disorders, including
neurodegeneration, cancer development, and progeroid syndromes. DNA double-strand breaks (DSBs) are the
most deleterious type of DNA damage, which, if unrepaired, even a single DSB can initiate cellular dysfunction,
tumorigenesis, and accelerated aging. DSBs are repaired via two distinct pathways: the high-fidelity homologous
recombination pathway or the more error-prone non-homologous end-joining pathway. However, the critical
molecular steps underlying the regulation of these pathways are still not completely understood. The long-term
goal of my research program is to determine the underlying regulatory mechanisms of the multi-protein and multi-
step process required to coordinate the repair of DNA damage. DNA resection is a key step in DNA repair
pathway choice, which involves the degradation of the 5’ DNA strand of a DSB to form a long 3’ single-stranded
DNA overhang used for homology-directed repair. This process requires the precise coordination of a dynamic
multi-enzyme machine consisting of multiple nucleases, helicases, and regulatory proteins to degrade DNA
along chromatin. However, a mechanistic description of how these enzymes assemble and are regulated at a
single DNA break still needs to be discovered. This proposal aims to understand how this multi-enzyme complex
comes together to coordinate its activities to prevent genome instability at the molecular level. In particular, we
will answer fundamental questions regarding human genome maintenance, including: (1) How does DNA
resection occur along chromatin? (2) How is DNA resection terminated (3) How is the DNA resection machinery
utilized beyond DSB repair, such as at telomeres, to prevent genome instability? Deciphering these critical
molecular events remains challenging because traditional approaches cannot directly observe the dynamic
assembly of multiple DNA repair proteins on the same DNA molecule. We will use cutting-edge single-molecule
fluorescence microscopy techniques, along with cryo-electron microscopy and biochemical techniques, to map
the dynamics of DNA repair proteins at DSBs and telomeres. Together, this work will provide a better
understanding of the complex spatial and temporal organization of key proteins during DNA repair and will
undoubtedly provide new insights into how the accumulation of DNA damage results in the loss of genomic
integrity, leading to tumor progression or accelerated aging syndromes.

Public health relevance
PROJECT NARRATIVE The accumulation of DNA damage is a constant threat to each of our cells and a driver of genome instability. This proposal aims to dissect how human DNA repair proteins coordinate their activities during the repair of DNA double-strand breaks, the most toxic DNA lesion, and at telomeres. Successful completion of the proposed projects will advance our understanding of human DNA repair and provide insights into how the loss of these key proteins leads to human diseases, including cancer and neurodegeneration.